Drug Screening for Neuroprotectants in Novel Zebrafish Models of Retinitis Pigmentosa

PROJECT SUMMARY
Retinitis pigmentosa (RP), an inherited retinal degeneration (IRD) disease, is characterized by primary rod
photoreceptor death followed by cone cell death; this results in irreversible vision loss. The rate of cell death in
RP is relatively slow, providing a protracted time window for therapeutic intervention. However,
pharmacological intervention capable of promoting photoreceptor survival remains an unmet need. While many
mouse RP models have been established, accelerating drug discovery by conducting large-scale drug screens
in mice is impractical. Zebrafish, however, are an established system for modeling human disease and testing
therapeutic compounds. In particular, our previous studies have shown zebrafish are especially valuable for
large-scale phenotypic drug screens. Thus, we generated genetic zebrafish RP models by knocking out RP
associated genes (e.g. rho, pde6a, and pde6b) with fluorescently labeled rod photoreceptors for easy
phenotype monitoring. We identified five models which exhibit various rates and severity of rod cell loss, a key
feature of RP. In addition, while the disease etiology is unclear, our preliminary data and recent studies
suggest that poly-ADP ribose polymerase (PARP) signaling, a key regulator of the parthanatos cell death
pathway, plays a significant role. Therefore, we propose to utilize new zebrafish RP models to investigate
photoreceptor cell death mechanism(s), and perform an in vivo phenotypic drug re-purposing screen
to identify small molecules that preserve degenerating photoreceptors. In Aim 1, we will measure cellular
changes and rod photoreceptor degeneration in the new RP models. In addition, we will evaluate the effect of
suppressing poly-PARP signaling, a hall mark of PARP1 activation, to determine if photoreceptor degeneration
is ameliorated. This will be accomplished using PARP inhibitors and knocking out PARP1. We will assess how
the extent of rod degeneration affects visual function by conducting visual behavior assays with the new RP
models. In Aim 2, we will use a phenotypic drug screening platform we developed to identify compounds
promoting rod photoreceptors survival in our RP models. We previously screened ~3,000 drugs in over
350,000 zebrafish larvae with inducible rod degeneration and successfully identified retinal neuroprotectants
showing efficacy in both fish and mouse models. Here, we will screen ~200 hit drugs, mostly human-approved,
from that project. In Aim 3, we will validate the identified neuroprotectants in three RP genetic mouse models.
This cross-species drug discover approach will accelerate the translation of identified drug for clinical trial, an
approach which can applied to a number of degenerative disease models. Therefore, completion of this project
will provide insight into the molecular basis of RP pathogenesis and identify compounds for RP clinical trials.

Public health relevance
PROJECT NARRATIVE Inherited retinal degeneration diseases like retinitis pigmentosa (RP) are caused by genetic defects leading to photoreceptor cell loss, irreversible loss of vision and eventual blindness. However, it is unclear how photoreceptors die or how to slow/stop/reverse this process. To better understand the disease mechanism and develop new therapies, we propose to: investigate whether the PARP dependent cell death pathway acts as a common RP mechanism; identify compounds which promote photoreceptor survival in new RP zebrafish model via perform in vivo phenotypic drug screening; and validate identified compounds in established mouse RP models.